Health, Air Pollution, and Population Initiative in Education and Science Training (HAPPIEST)

The overall goal of this project is to train University of Utah (UOU) undergraduate students in air pollution-related health research through a faculty-mentored summer program called Health, Air Pollution and Population Initiative in Education and Science Training (HAPPIEST). Specific aims are to:
AIM 1. Implement a comprehensive strategy to recruit UOU students into the HAPPIEST R25 program.
AIM 2. Immerse undergraduate students in a mentoring “community of practice” founded on an interdisciplinary, team-based approach to environmental health research, specifically as it relates to air pollution.
AIM 3. Utilize formative and summative evaluation to improve the quality and effectiveness of HAPPIEST as well as inform future undergraduate research training programs.
The “community of practice” is comprised of four research teams, each with two undergraduate students, one graduate student training coordinator, and at least one faculty mentor. Teams will work on locally-relevant air pollution and health research, with the potential for interdisciplinary integration across teams. HAPPIEST will serve a total of forty undergraduates over the five years of the project. The program directors will implement strategic activities for student recruitment, research training, professional development, and mentoring. Using an asset-oriented approach designed to build on student strengths, HAPPIEST activities will prepare students for placement into competitive graduate programs in the environmental health sciences. The project is of great

Public health relevance
The proposed project seeks to train University of Utah undergraduate students in air pollution-related health research through the transdisciplinary faculty-mentored summer program Health, Air Pollution and Population Initiative in Education and Science Training (HAPPIEST). The proposed project’s main contributions to public health are twofold: (1) HAPPIEST prepares additional students to enter STEM research, thereby growing the pool of talented scientists; (2) the program advances knowledge in environmental health science thereby informing innovative solutions for air pollution-related health problems in the Salt Lake Valley and beyond.